Characterization of drinking water contaminants and perinatal health effects in disadvantaged communities

PROJECT 1: SUMMARY/ABSTRACT
Project 1 of the UC Berkeley Superfund Research Center will conduct discovery- and community-driven
research in some of California’s (CA) most vulnerable communities to elucidate the perinatal health effects
associated with exposures to drinking water contaminant mixtures (Aim 1), characterize the presence of
chemical contaminants in drinking water of current and emerging health concern (Aim 2), and report back
results to participants, communities and agency decision-makers to inform public health actions (Aim 3). Over
three quarters of the public water systems that are out of compliance are in just 7 of CA’s 58 counties in the
southern San Joaquin (Tulare Lake Basin), and Salinas Valleys, where industrial and agricultural activities
have resulted in elevated levels of hazardous chemicals in drinking water. These contaminants include arsenic,
nitrate, pesticides, hexavalent chromium, and per- and polyfluoroalkyl substances (PFAS), which each have
documented health effects such as carcinogenicity, developmental effects, and endocrine disruption. That
these exposures occur in disadvantaged communities that are disproportionately Latinx raises environmental
justice concerns and underscores the need for community-engaged research. Project 1 proposes research
through the auspices of the Water Equity Science Shop (WESS), a multidisciplinary collaboration that includes
the Community Water Center, the University of California at Berkeley and Los Angeles, Silent Spring Institute,
and the CA Office of Environmental Health Hazard Assessment. Together WESS members will collaborate
with US EPA’s Center for Computational Toxicology and Exposure and BC Labs to carry out the project aims.
We will assess the perinatal health effects of multiple drinking water contaminants found in community water
systems and domestic well areas in the Salinas Valley and Tulare Lake Basin using mixtures methods and
machine learning to characterize heterogeneous effects of contaminants on fetal growth outcomes in a
demographically diverse study population (Aim 1: N=~740,000 births). We will recruit and sample tap water
from 100 households in the same regions to characterize drinking water threats from regulated and novel
unregulated compounds using data-driven methods, including dasymetric mapping techniques, to identify and
prioritize disadvantaged communities for study testing. We will then apply targeted and non-targeted analyses
of tap water samples to characterize the presence of multiple regulated and unregulated novel compounds of
current and emerging concern for cancer, developmental toxicity, and endocrine disruption (Aim 2). Finally, we
develop and deploy novel digital tools for report back of individual and aggregate contaminant measurements
to households and stakeholders to elucidate solutions to prevent and reduce exposures (Aim 3). The
combination of prior successful partnership, scientific expertise, and deep community knowledge makes the
WESS well-suited to conduct the collaborative science needed to effectively address drinking water threats
and associated health risks in CA’s most vulnerable communities.

Public health relevance
PROJECT 1: PROJECT NARRATIVE Project 1 will apply innovative scientific methods and a community-based research approach to characterize the presence of multiple regulated and unregulated/unmonitored drinking water contaminants, and advance understanding about the perinatal health effects of drinking water contaminant mixtures in some of California’s most vulnerable communities. Knowledge generated from this work, including the effects of drinking water exposures on birth outcomes, tap water sampling results for contaminants of current and emerging health concern such as PFAS, nitrate, arsenic, and hexavalent chromium, will benefit affected communities through novel and ethical report-back to participants, communities, and agency decision-makers that informs public health strategies and elucidates solutions to prevent and reduce harmful drinking water exposures among community water system and domestic well users in California.